Population Facing Research

Abstract Shared Resource 09: Population-Facing Research (PFR-SR)
The Population-Facing Research Shared Resource (PFR-SR), established as a Developing SR in January 2018,
aims to provide state-of-the-art technology services and consultation for population-facing researchers research
(e.g. real-time evaluation of pollution exposures in individuals commuting in Los Angeles traffic; high-resolution
genetic admixture studies with precise identification of Indigenous and African tribal ancestry; device technology
to measure the impact of a behavioral intervention on movement – sitting, standing, walking, running).
Specific Aims of PFR-SR:
Aim 1. Develop curation and analytic tools to evaluate cancer risk on multiple levels of scale
(populations - cohort curation; neighborhoods - real-time analysis of the built environment;
individuals - evaluate movement of individuals participating in risk-assessment and behavioral
trials).
Aim 2. Provide tools to investigate the impact of ancestry and environmental exposures on cancer risk.
Aim 3. Consultation and experimental design expertise for new and established investigators.
Population-facing research is becoming more complex; increasingly studies incorporate device technology, high-
resolution genetic admixture analysis, and evaluate, in real-time, the interaction between trial subjects and the
built environment. In response, the PFR-SR provides services that 1) require high-level expertise and 2) cannot
be accomplished by single investigators alone in a cost-effective manner. Users include all five COHCCC
programs and reflect the breath of scientific expertise of COHCCC population-facing researchers.
Many of our services are information technology-based and/or consultation and design, therefore our overhead
is low; this allows us to be nimble and rapidly respond to the rapidly changing technology needs of our users.
PFR-SR services are focused on NIH/NCI-funded science and determined by a survey of key members. Key
services are vetted by the Shared Resources Steering Committee, PFS-SR Internal Advisory Board, and our
COHCCC External Advisory Board. The PFR-SR Director meets biannually with SR Leaders from Research
Pathology and Biostatistics & Mathematical Oncology. This bi-directional communication ensures that 1) PFR-
SR services synergize with services provided by other SRs and are non-duplicative and 2) there is seamless
translation of data and information from one SR to the next.
Members Utilization by %Revenue 2017–21: 100 Total (14.1 MCBC, 2 DCT, 0.3 CI, 0.9 HM, 82.7 CCPS)
Publications by Members: 34, 7 with Impact Factor >10
Grants Supported: 21 Total (1 DoD, 10 NCI of 17 NIH (11 R01, 2 U01))